Electrical Coupling of Circulating Immune Cells to Peripheral Tissues

Abstract: Peripheral injury responses require sophisticated interactions of target tissues, immune cells and
primary sensory neurons. Crosstalk between these systems is essential for post-injury muscle repair and
nociception. While a great deal is known about the role of the immune system in functional restoration of
muscles and in pain development, it is not known if physical coupling of circulating immune cells to myofibers
or neurons after injury directly modulates both of these unique biological processes. Information on novel
interactions between muscles, the peripheral nervous system and immune cells could significantly advance
understanding of myalgia and muscle repair. The goal of this study is to determine if infiltrating immune cells
electrically couple to myofibers or neurons after injury to dually modulate functional muscle repair and
nociception. Recent reports suggest that, after injury, connexin 43 (Cx43) gap junctions may form between
macrophages and myofibers to modulate repair. It has also been shown that similar gap junctions form
between adjacent neurons within the dorsal root ganglion (DRG) to regulate nociception. In the heart,
electrical coupling between resident macrophages and cardiomyocytes is crucial for proper atrioventricular
conduction. It is therefore reasonable to hypothesize that immune cells electrically couple to myofibers and
nociceptors after skeletal muscle damage to coordinate responses to injury and dually modulate tissue repair
and pain. Aim 1 (R61 Phase) will determine if electrical coupling of macrophages to nociceptors modulates
incision-related hypersensitivity. This study will use novel transgenic strategies to specifically knockout Cx43
in macrophages in mice with hind paw muscle incision. This will be used in conjunction with chemogenetic or
sono-genetic activation of macrophages. Impact of Cx43 knockout and macrophage activation will be
assessed with our ex vivo muscle afferent recording preparations, muscle pain-related behavioral tests and
calcium imaging (using GCaMP6 reporters) in co-cultures of macrophages and primary DRG cells. Aim 2
(R61 Phase) will use similar groups to determine if electrical coupling of infiltrating macrophages to myofibers
facilitates repair of muscle tissue after incision. The impact of these manipulations will be determined using
calcium imaging of hind paw muscle cells, electromyography/ compound muscle action potential recordings in
vivo, and anatomical analyses of muscle membrane integrity. Aim 3 (R33 Phase) will further explore the
functions of macrophage electrical coupling using different transgenic combinations, inhibitory chemogenetics
and more severe models of muscle injury. Results will allow determination of novel means of communication
between circulating immune factors and the peripheral structures they are affecting. Data will provide novel
insights into muscle injury responses that will go well beyond the incremental expansion of current reports.
These insights could identify a novel target for therapeutic intervention for pain or muscle repair in numerous
muscle injury states.

Public health relevance
NARRATIVE The results of the proposed research will further our understanding of the complex interactions of immune cells, muscle tissue and sensory neurons and how these cellular systems coordinate appropriate responses to peripheral injuries. Data will provide novel information for use in the development of new avenues of research and therapies for pain or muscle repair and how the immune system plays a dual role in regulating these processes.